A Cerebrovascular Basis for Sex Differences in Alzheimer's Disease Risk

ABSTRACT
The overall goal of this study is to characterize sex differences in neural systems underlying Alzheimer’s
disease (AD) progression, and to test a cerebrovascular (CV) model explaining these sex differences. This
study takes advantage of a unique opportunity to recruit from two longitudinal R01 on pre-clinical AD to
achieve a well-characterized cohort of older adults with identical PET (amyloid and tau) and 7T MR imaging
protocols.
Recently, we have found that cognitively normal women and men with high amyloid burden show different
patterns of hippocampal connectivity. The different patterns of connectivity between women and men are
similar to what we and others have found in relation to cerebral small vessel disease (SVD). Women with high
amyloid burden and Individuals with high SVD burden share similar patterns: higher local hippocampal-medial
temporal lobe (MTL) connectivity and lower distant hippocampal-prefrontal connectivity. Further, recent data
have shown that women with high amyloid burden also have higher entorhinal cortical tau deposition and faster
cognitive decline, than men. These converging findings point to a CV mechanism, particularly cerebral SVD,
that is underlying the faster progression from amyloid positivity to neurodegeneration, and subsequent
cognitive decline in women.
Using advanced 7T imaging techniques, e.g., Time of Flight angiography imaging and susceptibility weighted
imaging, this study is able to visualize both the arteriolar anatomy and the venular anatomy. A new 3D vein
segmentation algorithm BrainVein is developed and validated in this study, which allows for a faster (compared
to the traditional manual tracing method), more reliable and accurate segmentation of small veins. Besides the
traditional markers of SVD (e.g., white matter hyperintensities -WMH), this study will have novel morphological
markers of the arterioles and venules including Arteriolar Tortuosity Index (ATI), Venular Tortuosity Index (VTI),
Venular Branching Pattern (VBP), and Venular Luminal Variability Index (VLI). These novel markers represent
specific, early and dynamic features of cerebral SVD and are also modifiable through lifestyle changes and
medical management.
With this well-characterized cohort, in Aim 1 we will identify SVD markers that differ between women and men,
and characterize the associations between SVD markers with AD risk factors. In Aim 2 we characterize sex
differences in amyloid- and tau-related functional changes, and in Aim 3, we will identify specific SVD markers
that can explain sex differences observed in Aim 2. Results from these aims can inform the sex-specific
prevention and treatment strategy of AD.

Public health relevance
NARRATIVE Prior work has identified a pre-clinical stage of Alzheimer’s disease (AD), when cognition is not significantly impaired, but there is significant cerebral amyloidosis. This study uses advanced neuroimaging methods to characterize sex differences in pre-clinical AD. Since small vessel disease (SVD) is the most salient model explaining sex differences in AD risk, we use SVD specific ultra-high field MR imaging along with functional MRI to identify sex-specific risk factors and pathways to AD. With no current cure for AD and with the emerging therapies for SVD, identifying modifiable SVD markers, as in this study, can serve as targets for prevention or delayed progression of AD.